Training in Health Services Research for Vulnerable Populations

ABSTRACT
Since 2013, our AHRQ T32 program has successfully recruited diverse fellows and prepared them for health
services research careers. We have trained 24 researchers, resulting in 35 presentations and 26 publications.
Five of our trainees are still engaged in the training program and are on track to meet all our stated objectives;
of the nineteen graduates, seven (six postdoctoral and one predoctoral who completed his PhD) have
appointments at academic institutions and two are completing their PhDs at the BUSPH. This competitive
renewal builds on our successful program in several important ways. We are expanding the diversity in content
by including trainees and mentors from the Department of Surgery. We are also adding additional didactic and
training and experiential opportunities and social determinants of health and health equity. Our interdisciplinary
predoctoral and postdoctoral fellowship aims to produce Family Medicine, General Internal Medicine,
Pediatrics, Surgery and Public Health researchers who will lead efforts to improve health care delivery for
underserved patients. The four objectives of our program are to: (1) Recruit and retain high-quality,
diverse candidates interested in research careers focused on improving health care quality, access, and
delivery for underserved patients; (2) Provide predoctoral and postdoctoral fellows with comprehensive
research training; (3) Produce graduates who will conduct research on health care quality, delivery, and
health outcomes for low-income populations and whose research translates to systems change; and (4)
Evaluate our program for continuous improvement. The program is led by Dr. Marc LaRochelle, an
experienced researcher and mentor, and Co-Directed by an interdisciplinary team of senior scientists. We have
established four pedagogical structures essential to training research fellows: (1) Intensive mentoring; (2)
Boston University School of Public Health (BUSPH) courses culminating in a Master’s in Population Health for
postdoctoral fellows and a PhD for predoctoral fellows; (3) Interdisciplinary academic seminars; and (4)
Supervised conduct of at least two research projects. Predoctoral training includes the first 3 didactic years of
the PhD program. Postdoctoral training is 2 years. Each year, we will train 3 predoctoral and 3 postdoctoral
fellows. Fellows will become health service researchers focused on health care quality, delivery, and outcomes
for low-income populations. We track graduates 1, 5, and 10 years after graduation (goal: >85% enter research
careers focused on improving healthcare quality; >70% remain in health services research after 3 years; >50%
lead efforts to implement new care models and have >1 funded research within 5 years).

Public health relevance
PROJECT NARRATIVE In 2013, Boston Medical Center, New England’s largest safety-net hospital, established an interdisciplinary predoctoral and postdoctoral AHRQ fellowship program and have successfully trained Family Medicine, General Internal Medicine, Pediatrics, and Public Health researchers to improve health care delivery for underserved patients. This competitive renewal will expand our program by including trainees from the Department of Surgery, and add social determinants of health, health equity, and community engagement didactic and experiential learning opportunities. The four objectives of our program are to: (1) Recruit and retain high-quality, diverse candidates interested in research careers focused on improving health care quality, access, and delivery for underserved patients; (2) Provide predoctoral and postdoctoral fellows with comprehensive research training; (3) Produce graduates who will conduct research on health care quality, access and delivery for low-income populations and whose research translates to systems change; and (4) Evaluate our program for continuous improvement.